PrEP and substance use among sexual minority young adults

This application requests support and training for a New/Early Stage Investigator in research independence to
conduct HIV and substance use prevention research. The PI and mentorship team will explore sexual identity,
sexual identity disclosure, and minority stress as it relates to pre-exposure prophylaxis (PrEP) linkage to care
and substance use experiences among African American and Hispanic/Latino young men who have sex with
men (AA/HL YMSM). Substance use compounds HIV risk and disrupts the PrEP care continuum. This
proposal is focused on AA/HL YMSM because of the high incidence of HIV infection among these populations
and disproportionately high rates of substance use. PrEP is a key approach to addressing the HIV epidemic,
but uptake is unequal across populations at elevated risk for HIV. Furthermore, the PI has found that rates of
substance use are increasing among sexual minority YMSM. Research has largely failed to consider the role of
interpersonal, community, and societal factors that thwart PrEP uptake and exacerbate substance use among
AA/HL YMSM. A robust training plan is proposed that includes three core areas for skill development: (1) HIV-
related intervention development; (2) qualitative methods to gain in-depth understanding of perspectives and
experiences of minorities with substance use; and (3) content expertise in HIV prevention, problem substance
use, and minority stress. The plan involves a mentorship team of six HIV and substance use prevention
scholars, individualized trainings, coursework, and professional conferences. Career goals include a
subsequent R01 application and the creation of a sexuality-focused niche in HIV and substance use
prevention. Career development will take place at the University of Connecticut in collaboration with leading
institutions and centers in New England. Based on our preliminary work, we propose three studies that explore
the role of sexual identity and disclosure in PrEP and substance use experiences across the PrEP care
continuum. We will address three specific aims. Specific Aim 1: Informed by a minority stress model, evaluate
PrEP uptake and substance use among YMSM in a national cohort. We will collect new national data
(N = 3,000 18 to 29-year-old AA/HL YMSM) to evaluate how diverse interpersonal, community, and societal
factors affect PrEP uptake and substance use. Specific Aim 2: Define the PrEP care continuum for YMSM with
and without substance use (from Aim 1). We will do so via four biyearly follow-up surveys (N = 300) over 24
months from participants in areas of high HIV incidence. Specific Aim 3: Perform semi-structured interviews
among YMSM for future sexuality-informed PrEP/SU interventions (N = 30). How multiple barriers are related
to substance use and PrEP uptake will be explored. Additionally, using the ADAPT-ITT model and based on
previous findings, the we will identify the modifiable characteristics among current interventions that can be
applied to prevention programs targeting YMSM. This project has the potential to systematically address the
lack of attention to sexuality in interventions that focus on high rates of HIV and substance use.

Public health relevance
PROJECT NARRATIVE This study examines how sexual orientation, identity disclosure, and minority stress experiences relate to HIV prevention and substance use across the pre-exposure prophylaxis (PrEP) care continuum among African American and Hispanic/Latino young men who have sex with men (YMSM). The investigation of differential PrEP uptake and linkage to care on the basis of sexual identity, race/ethnicity, and disclosure of sexual identity will identify under what conditions YMSM of color are most vulnerable to HIV infection and unhealthy substance use. The examination of these factors across multiple levels (e.g., interpersonal, community, societal) highlight critical points for individual-level prevention strategies to eliminate disparities in HIV infection and substance use across vulnerable populations of young people.